Research Project 2: PFAS and Liver Health in Latino Youth: A Longitudinal Multi-Omics Study

Per- and polyfluoroalkyl substances (PFAS) are ubiquitous, persistent chemicals that can accumulate in the
human body for long periods of time and are major water contaminants around Superfund sites. PFAS partition
to the liver and robust evidence generated by animal toxicological studies shows that PFAS are hepatotoxic,
even at low levels of exposure. However, human studies are scarce and the mechanisms of PFAS effects on
human liver disease are not well understood. Previous human studies underscore limitations such as small
sample sizes, cross-sectional study designs, lack of gold standard imaging measures of liver disease, lack of
evaluation of PFAS mixtures, and lack of focus on susceptible populations who are disproportionally affected by
metabolic dysfunction-associated steatotic liver disease (MASLD), the most prevalent liver disease in the U.S.
To date, there is no current Superfund Center that specifically addresses the health effects of PFAS in relation
to their effects on liver disease. Project 2 aims to address the Superfund Research Program Mandates 1 & 2
and assess the PFAS effects on hepatic fat accumulation in susceptible populations by using innovative
statistical methods for exposure mixtures and pharmacokinetic modeling, repeated magnetic resonance imaging
(MRI) measurements of liver fat, and integration of high-dimensional omics in a longitudinal study design. Our
preliminary results support our hypothesis that high exposure to PFAS is associated with increased hepatic fat
accumulation in adolescents, potentially via dysregulated metabolic and inflammation pathways. Relying on two
already established cohorts in Southern California who live near multiple Superfund sites, this project will
efficiently utilize wide range of exposures and gold standard outcome data covering a 20-year span and two
different life periods (adolescence and young adulthood). We propose to use high-throughput metabolomics and
proteomics, providing broad coverage of inflammation and metabolism-regulating omics profiles to
comprehensively characterize dysregulations in biological pathways associated with PFAS hepatotoxicity. Our
specific aims are: (1) To examine prospective associations of exposures to individual PFAS and PFAS mixtures
with longitudinal changes in hepatic fat fraction (HFF) in youth; (2) To identify omics signatures that will serve as
biomarkers of PFAS exposure identified in Project 1; (3) To identify risk profiles for increased HFF in youth using
innovative statistical methods that integrate data on PFAS exposures, multi-omics measures, and social
determinants of health; and (4) To apply a causal inference framework and estimate potential health effects for
real-life PFAS exposure interventions [informed by Project 4, and the Community Engagement Core (CEC)].
Collectively, this study will increase our understanding of the impact of PFAS exposures on liver health in youth,
who face increasingly high burdens of MASLD. Findings could be used in clinical practice for risk stratification in
youth and tailored personalized precision prevention approaches for high-risk populations near Superfund sites,
and other contaminated areas in the US.

Public health relevance
PROJECT 2: PROJECT NARRATIVE PFAS are major water contaminants around Superfund sites, and exposure to PFAS can affect liver health and partly explain the excess burden of liver disease in the U.S. Project 2 will be the first cross-disciplinary study to assess the PFAS effects on hepatic fat accumulation in susceptible populations by using innovative statistical methods for exposure mixtures, gold standard imaging measurements of liver fat, and integration of high dimensional omics in a longitudinal study design. Findings will contribute evidence to inform precision prevention strategies for liver disease in high-risk populations.